A Data Coordinating Center for ENCODE

Project Summary
The goals of the ENCODE Data Coordinating Center (DCC) is to support the ENCODE Consortium by defining
and establishing a strategy that connects all participants to the data and by creating avenues of access that
distribute these data to the greater biological research community. The ENCODE Consortium brings together
laboratories that generate complex data types via experimental assays with laboratories that integrate these
unique data using computational analyses to discover how chromosomal elements function together to define
human cells and tissues. The DCC's participation enhances the data created by these laboratories through the
creation of structured procedures for the verification and validation of all submitted data and providing
processes for the documentation of metadata that describe each biological sample and assay method. To
facilitate access to all the data created the DCC will construct a state of the art data warehouse. The DCC will
design and development robust software to enhance the data submission and unified data processing
pipelines, the organization and access to metadata and the data warehouse. In addition, we will develop and
maintain the ENCODE Portal that will be the primary entry point to the wealth of experimentally determined
information as well as results of computational analyses. The Portal will integrate these data resources and
make them available via enhanced search and browsing capabilities. Tools will be implemented to aid
discovery by both experienced bioinformaticians and naïve laboratory staff. The DCC will evolve into a
substantial service organization allowing biomedical research to take full advance of the ENCODE results. To
this end the DCC will provide documentation via many media including written documentation, video tutorials,
webinars, and meeting presentations. The DCC, DAC, production laboratories and AWG will be tightly woven
together to create the ENCODE Consortium.

Public health relevance
Relevance to Public Health, Project Narrative The ENCODE Consortium defines standards for reproducibility, quality control, validation metrics, metadata models and gold standards datasets for genomic scale assays of the chromosomal functional elements encoded by the human genome. The ENCODE Data Coordination Center provides the conduit for the consortium data and standards to be shared. These standards and data are essential for understanding the nature of human health and the treatment of disease.